Regulation of erythroid iron metabolism by the CLPX unfoldase

ABSTRACT
During terminal erythropoiesis, erythroid cells produce significant quantities of heme and heme intermediates
which must be coupled to hemoglobin production and iron uptake. Dysregulation of heme synthesis can cause
toxic accumulation of heme intermediates and heme deficiency, leading to diseases such as iron overload,
anemia and porphyria. We have demonstrated that mitochondrial CLPX, a member of the ubiquitious AAA+
(ATPases associated with various cellular activities) protein unfoldases family, plays a key role in erythroid
differentiation by direct regulation of heme synthesis. CLPX functions as a ring-shaped homo-hexamer and is
best understood for its function in a proteasome-like enzyme complex with the peptidase CLPP (the CLPXP
ATP-dependent protease). In erythroid cells, CLPX is essential for heme synthesis by regulating the terminal
steps of porphyrin synthesis and mitochondrial iron metabolism. This finding is conceptually significant as
ALA synthesis has until now been understood to be the rate limiting step of porphyrin synthesis. In addition,
although the heme synthesis and iron metabolism pathways are coregulated, the mechanisms by which this
occurs are poorly understood. This proposal tests the conceptually innovative hypothesis that CLPX
coordinates the terminal steps of the heme synthesis pathway with mitochondrial iron metabolism and is a key
regulatory node for coupling heme synthesis and iron metabolism to the needs of the erythroid cell. The goal of
this proposal is to identify the mechanisms by which CLPX regulates erythoid heme synthesis and
erythropoiesis. This will be accomplished by Specific Aim 1, which examines the novel mechanisms by which
CLPX regulates the terminal enzymes of the heme synthesis pathway, PPOX and FECH. Specific Aim 2 will
identify the mechanisms by which CLPX regulates mitochondrial iron metabolism and the role of iron status in
modulating diseases caused by mutations in the CLPX gene. Completion of these specific aims will
fundamentally inform our understanding of “housekeeping” proteins like CLPX can have tissue specific
functions in erythroid cells. These findings are also of translational significance as they will enable us to
determine how to manipulate iron status to treat specific types of iron/heme disorders.

Public health relevance
PROJECT NARRATIVE The proposed project aims to biochemically characterize the role of the ubiquitous mitochondrial protein unfoldase CLPX in erythroid heme synthesis. Completion of this project will fundamentally enhance our understanding of the mechanisms underlying diseases caused by defects in heme synthesis, such as anemias, porphyrias and mitochondriopathies, and how tissue-specific factors regulate and modify ubiquitous metabolic pathways. Because a disproportionate number of anemic patients are women and children, the success of this project will have particular impact on the management of their health.